Erythrocyte Autophagy Proteins as Potential Non-opioid Novel Targets for Pain in Sickle Cell Disease

PROJECT SUMMARY/ABSTRACT
The long-term objective of this proposal is to develop non-opioid novel molecular targets to reduce
the pain suffering and mortality attributed to sickle cell disease (SCD), by identifying to upstream
messengers of acute and chronic pain signaling. Mitochondrial retention in SCD red blood cells
is recognized now to be a major contribution in SCD pathogenesis. However, the downstream
molecular mechanisms related to pain and mitochondrial retention is not investigated. Our
preliminary data suggested that dysregulated autophagy byproducts of Cathepsins, GABARAPs
and synucleins released during lysis of RBCs of SCD red blood cells have potential to trigger pain
episodes in SCD patients. Here, we hypothesized that specific autophagy proteins including
CTSO, CTSW and SNCB along with other known DAMP signaling molecules generated from
SCD RBCs contribute pain in SCD through interaction with pain signaling molecules in
endothelium and neurons. This notion is supported by preliminary data indicating that SCD RBCs
with increased levels of autophagy proteins not only in SCD RBCs but also in plasma compared
to controls. To address this hypothesis, two aims are proposed. The first aim will determine
whether the pain severity of SCD is associated with expression and activity levels of autophagy
proteins in both pediatric and adults SCD patients. The second aim is to determine whether
inhibiting autophagy proteins can reduce pain signaling and pain behaviors in an SCD mouse
model and characterize the molecular interaction of autophagy proteins Synucleins (SNCA,
SNCB), Cathepsins (CTSB, CTSO. CTSW) and GABARAPs (L1 and L2) with pain signaling
molecules. It is anticipated that the result of these studies will make understand the unique
mechanisms of pain in SCD and will ultimately lead to clinical trials to assess new pharmacological
interventions to reduce the need for opiates to manage pain.

Public health relevance
PROJECT NARRATIVE Sickle cell disease (SCD), caused by a single point mutation of the -globin gene, is the world’s most lethal genetic blood disease. Our Identification of abnormally retained mitochondria associated with overexpression of pain-related messenger molecules in the red blood cells of SCD patients suggests that targeting these downstream effector molecules is the best strategy to manage pain effectively without opioids. This study will help identify biomarkers to help clinicians predict which individuals are at risk for increased pain and develop new molecular targeted therapies to reduce pain by understanding the link between the specific red blood cells autophagy proteins and pain severity in the SCD animal model.